Neuronal Development, Injury and Repair in the Retina

Project Summary/Abstract Injuries or diseases that kill retinal neurons and receptors block vision at it source. The resulting blindness is permanent. The inability to repair in the retina is a hallmark of the human central nervous system; neurons that die are not replaced and functions that are lost are not recovered. This bleak outcome is a driving force for research on neural stem cells and the field of regeneration biology. The long-term objective of this project is to elucidate the mechanisms that regulate the birth, death and regeneration of neurons and photoreceptors in the vertebrate retina. This program of research utilizes the zebrafish, because the fish retina is the only vertebrate CNS tissue where intrinsic stem cells can regenerate a single neuronal type that integrates into an existing circuit or can regenerate all cell types that completely restore the original tissue. Thus, investigating stem cell-based neuronal and photoreceptor regeneration in the teleost retina will advance our knowledge of mechanisms that govern the ability of intrinsic stem and progenitor cells to restore neural circuits in the injured brain. The resulting knowledge will guide the therpeutic use of transplanted stem and progenitor cells to treat retinal injuries, blindness and disease. Three Specific Aims are proposed, each directed toward revealing mechanisms that regulate the genesis and regeneration of photoreceptors. Specific Aim 1 will investigate the function of the bHLH transcription factor, NeuroD, in both the developing and regenerating retina. Specific Aim 2 will test the hypothesis that microglia play a neurogenic role during photoreceptor regeneration. Specific aim 3 will test the hypothesis that the soluble growth factor, midkine-a, controls aspects of retinal development in larval zebrafish and photoreceptor regeneration in adults. Together these specific aims represent a focused and integrated research program to test specific hypotheses of the biology and regulation of retinal development and neuronal regeneration in the vertebrate nervous system.

Public health relevance
Project Narrative: Photoreceptors initiate the first step in vision, and in the human retina the death of photoreceptors leads to permanent blindness. The Specific Aims descibed in this proposal will investigate the mechanisms by which intrinsic stem and progenitor cells regenerate photoreceptors in an adult retina. This work is highly relevant to human health, because it explores the molecular mechanisms employed by adult stem cells to repair the retina and brain and will provide information relevant to the therapeutic use of neural stem and progenitor cells in humans. __SpecificAimsTextDelimiter__ a. Specific Aims Our long-range goal is to understand the mechanisms that regulate the birth, death and regeneration of neurons and photoreceptors in the vertebrate retina. In the previous funding period, we identified and tested the function of soluble signaling molecules and a transcription factor, NeuroD, that we hypothesized regulate aspects of these events. The results of those studies supported our hypotheses and provided new information that leads us to experimentally investigate the function of cells and signaling molecules that we can now hypothesize play key roles in retinal neurogenesis and photoreceptor regeneration. For this funding period, three specific aims are proposed: Specific Aim 1. Test between the alternative [mechanisms] that during retinal development NeuroD function is cell autonomous or cell non-autonomous, test the hypothesis that NeuroD regulates photoreceptor regeneration [and identify molecular pathways through which NeuroD regulates photoreceptor regeneration.] In the previous funding period, we showed that among photoreceptor progenitors, the bHLH transcription factor NeuroD regulates cell cycle withdrawal and differentiation. Unresolved however, is whether NeuroD function is cell-autonomous or cell non-autonomous. We will determine whether NeuroD function is intrinsic to photoreceptor progenitors or if NeuroD mediates cell-cell or cell-extracellular matrix interactions. Based on NeuroD function during photoreceptor genesis, we will test the hypothesis that in the adult retina NeuroD also regulates photoreceptor regeneration. [Finally, to uncover mechanisms by which NeuroD controls photoreceptor regeneration, multiple approaches will be employed to identify the genetic pathway(s), which mediate NeuroD function.] Specific Aim 2. Test the hypothesis that microglia regulate aspects of regenerative neurogenesis. Array studies performed in the previous funding period identified growth factor genes that are induced in microglia during photoreceptor regeneration. One of these factors, progranulin-A, controls neurogenesis in the developing retina. From this observation and an emerging literature, we hypothesize that in the retina microglia are cellular effectors of neurogenesis during photoreceptor regeneration. Specific Aim 3. Test the hypothesis that midkine-a regulates retinal neurogenesis and photoreceptor regeneration. In the previous funding period, we showed that Midkine-a (mdka) is expressed in mitotic progenitors during retinal development and photoreceptor regeneration. From these data, we hypothesize that Mdka regulates aspects of both developmental retinal neurogenesis and photoreceptor regeneration. These Specific Aims will be undertaken using the retina of the zebrafish. The teleost retina is the only vertebrate central nervous tissue where intrinsic stem cells can regenerate a single neuronal type, which is integrated into existing synaptic circuits, or regenerate all cell types, which can fully restore the original tissue. Testing the cellular and molecular determinants of photoreceptor genesis and regeneration in the zebrafish retina will yield exciting and important results, which will expand our knowledge of intrinsic neural stem and progenitor cells and help identify core requirements of therapeutically transplanted cells.